MIT/Whitehead/Broad Computational Genetics Training Program

See instructions): We propose to establish a new interdisciplinaryresearch trainingprogram in Computational Genetics as a collaborative effort between MIT, the Whitehead Institute, and the Broad Institute of MIT and Harvard. The goal of this program is to train MIT students to be effective interdisciplinaryscientists, working as team members with biologists to develop new algorithms, tools, and approaches for analyzing genomic and genetic data and expressing this analysis in the form of principled predictive models. The program faculty will consist of five MIT EECS and Mathematics faculty, four Whitehead faculty members, and four members of the Broad Institute of MIT and Harvard. The major research disciplines of this program include: 1) the development of new approaches and algorithms for the analysis of data from genomics and genetics based experiments and studies; 2) approaches for the principled design of studies based upon past data; 3) the construction of computational models that explaincomplex phenotypes and biological phenomenon; 4) and the development of approaches for interpreting genomic, genetic, and clinical data relevant to human health and disease. It is proposed that four pre-doctoral trainees be supported in this program, each for a period of two years (a total of 8 slots). We have been runninga training program in this area for over seven years, and our students to date have made substantial contributionsto the field. Among our recent graduates are faculty at Stanford, Berkeley, Univ. of Washington, Princeton, Duke, and CMU. Our pool of applicants is unusually strong, with 592 applicants in 2008 in relevant sub-areas of Computer Science. Trainees in our proposed research training program will have a very rigorous technical and quantitativefoundation from the MIT graduate program in Computer Science, combined formal interdisciplinary course work and a co mentorship arrangement between a Computer Science and a Biology faculty member. The strong technical skills present in our pre doctoral students have provided an excellent foundation for the creation of ground breaking new approaches and algorithms in Computational Genetics. RELEVANCE (See instructions): We will train scientists who can discover links between genetic informationand risks for human disease. These studies can suggest appropriate therapies for certain diseases and give clues towards the development of new therapeutics. As more data form Genome Wide Association Studies becomes available, we expect that genetic information will become an important component of preventative medicine.